TC99MP215 IN DETECTION AND LOCALIZATION OF ATHEROSCLEROTIC PLAQUE

To determine whether localization of an Tc99m labeled peptide directed to LDL receptor is capable of identifying active atherosclerotic plaque.